Deciphering Molecular Mechanisms of Calcium Homeostasis

PROJECT SUMMARY/ABSTRACT
Calcium is a critical mediator of many cellular processes, including muscle contraction,
mitochondrial activity, transcription, cell division, and synaptic vesicle release. Paradoxically,
calcium can also trigger cell death and cellular necrosis. Therefore, dysregulation in calcium
signaling can disrupt cellular homeostasis. Consequently, calcium levels need to be tightly
controlled. Indeed, defective calcium signaling has been implicated in many neurodegenerative
diseases, muscular dystrophies and heart disease. To understand the mechanisms regulating
calcium signaling and how defects in this process can lead to cellular dysfunction, we are
exploiting the model system Caenorhabditis elegans to identify critical processes that are
involved in the regulation of calcium handling. We have recently demonstrated that SEL-12, the
C. elegans presenilin ortholog, has a role in mediating endoplasmic reticulum-mitochondrial
calcium homeostasis. Disruption of presenilin function results in an increase in mitochondrial
calcium levels and alters mitochondrial metabolism promoting protein homeostasis collapse and
neurodegeneration. Presenilin is a highly conserved protein found from plants to humans that is
extensively found on endomembrane structures (e.g., endoplasmic reticulum and lysosome) of
most cell types. However, the role presenilin has in the endomembrane system is not clear.
Importantly, mutations in human presenilin are the most common cause of early onset familial
Alzheimer's disease. Despite the identification of the involvement of presenilin in Alzheimer's
disease over 20 years ago, the functional consequences of mutations in presenilin causing
Alzheimer's disease are not understood. To gain further insight into the role presenilin has in
mitochondrial calcium homeostasis and neuronal fitness, we have developed a novel and highly
selective RNA interference screen to identify gene products that meditate the elevated
endoplasmic reticulum to mitochondrial calcium signaling observed in sel-12 mutants. From this
screen, we have identified several proteins known to mediate endoplasmic reticulum calcium
release and mitochondrial calcium uptake but we also identified several gene products with an
uncharacterized role in endoplasmic reticulum and mitochondrial calcium signaling. We propose
to utilize a multifaceted approach that combines genetic manipulation, high resolution live cell
microscopy to analyze endoplasmic reticulum and mitochondrial dynamics, mitochondrial
activity assays, and behavioral assays to determine the role these gene products as well as sel-
12 have in mitochondrial health and neuronal fitness.

Public health relevance
PROJECT NARRATIVE Deregulation of calcium handling and mitochondrial function is implicated in most if not all neurodegenerative diseases as well as other age-related disease. Thus, the goal of the proposed research project is to resolve the molecular mechanisms underlying calcium regulation and mitochondrial function and, therefore, provide insight into the causes of and strategies to treat neurodegenerative disease.